Development of VesiVax Carbohydrate Conjugation Chemistry

DESCRIPTION: In response to PA-10-150, we will test the hypothesis that the VesiVax(R) Conjugatable Adjuvant Lipid Vesicle (CALV) platform can provide an efficient method to develop carbohydrate conjugate vaccines that stimulates superior immune responses to unconjugated carbohydrate antigens and also provides more flexibility to control the immune response to carbohydrate antigens over currently employed conjugate vaccine technologies. To demonstrate the utility of the VesiVax(R) CALV platform for this purpose, we propose to develop a polysaccharide conjugation technology with the commercialization goal of producing an easy-to-use modification to the VesiVax(R) CALV line of products. It is anticipated that successful execution of this project will provide a new tool that will enable immunologists and vaccinologists to evaluate their carbohydrate antigens of interest. Polysaccharides are emerging as promising vaccine targets for a variety of pathogens including viruses, bacteria, fungi, and cancers. In this SBIR Phase I application, we will develop a simple carbohydrate conjugation method that couples polysaccharide antigens to free amines on either a protein scaffold or liposomes containing lipid amines. Specifically, using the capsular polysaccharide Vi from Salmonella enterica (typhi) as our model carbohydrate antigen, we will couple Vi directly to VesiVax(R) CALVs containing a Toll-like Receptor 4 (TLR4) agonist or to a protein scaffold based on the mutant of diphtheria toxin known as CRM197 engineered to have a C-terminal cysteine residue (CRM197-Cys). The Vi-CRM197-Cys will then be conjugated to the VesiVax(R) CALVs. The VesiVax(R) Vi CALV conjugates containing the TLR4 agonist will then be tested in a mouse model of immunization to demonstrate the utility of the proposed approach.

Public health relevance
Successful performance of the proposed Specific Aims will test the hypothesis that the VesiVax(R) CALV platform can provide an efficient method to develop carbohydrate conjugate vaccines that are superior to unconjugated carbohydrate antigens and will provide an added benefit over currently employed conjugate vaccine technology through the ability to augment the immune response with VesiVax(R) CALVs containing different TLR agonists. Completion of the proposed studies is anticipated to lead to several significant outcomes. First, it will facilitate the introduction of a series of carbohydrat conjugation VesiVax(R) CALV kits that are easy-to-use, will provide a valuable tool for researchers to more quickly screen the immune response profiles elicited by a wide range of carbohydrate antigen candidates and can be manufactured cost effectively in compliance with cGMP regulations. Development of the proposed technology could potentially provide a major improvement in the ability to design carbohydrate-based vaccines against other infectious disease causing pathogens which have valid polysaccharide target antigens as well as potentially engineering vaccines against carbohydrate antigens associated with certain cancers. Lastly, the successful performance of these studies could directly lead to the identification of a candidate vaccine against Typhoid that could be further developed into a clinically useful vaccine.